Pediatric Recovery After Sepsis Treatment in the Pediatric Intensive Care Unit

PROJECT SUMMARY/ABSTRACT
Sepsis in children is a leading cause of death and morbidity, yet little is known about its impact on physical
function after hospital discharge. Building upon the candidate’s prior biobehavioral research and
accomplishments within the K99 phase, this R00 application will utilize translational approaches to explore the
potential role of pro-inflammatory mediators as they pertain to physical function in critically ill children who
survive sepsis and/or pneumonia in the Pediatric Intensive Care Unit (PICU). This proposed application aligns
well with the priorities of the National Institute for General Medical Sciences, “to support sepsis research that
uses new and emerging approaches.” The overall purpose of this R00 transition application, Maximizing
Opportunities for Scientific and Academic Independent Careers (MOSAIC) Postdoctoral Career Transition
Award to Promote Diversity (PAR-19-343), is to prepare the candidate for an independent career as a nurse
scientist with a robust program of research in pediatric critical care and symptom science. In the independent
phase (R00) of the study entitled, PEdiatric Recovery after sepSIS Treatment in the Pediatric Intensive Care
Unit (PERSIST-PICU), the candidate will conduct a prospective longitudinal cohort study to refine the initial
PERSIST-PICU multivariable model created throughout the K99 phase with new prospectively collected
inflammatory biomarkers and measures of functional status. Identification of critically ill children with sepsis
and/or pneumonia who are at-risk for physical dysfunction after discharge will provide an opportunity for early
intervention to optimize their physical function after critical illness. The candidate’s stellar collaborative
interdisciplinary team, tailored research plan and activities planned within this R00 application will prepare her
well for transition to independence as a nurse scientist in pediatric critical care and symptom science.

Public health relevance
NARRATIVE Child survivors of severe infection may experience long-term physical problems. This R00 application will comprehensively describe a cohort of critically children who survive sepsis and test the hypothesis that inflammation is associated with physical dysfunction after discharge from the Pediatric Intensive Care Unit. We will refine PEdiatric Recovery after sepSIS Treatment in the Pediatric Intensive Care Unit (PERSIST-PICU), a model predicting a child’s risk for physical dysfunction so future research can optimize physical function in critically ill children who need it most.